ADMIN CORE - Hematopoiesis in cardiovascular disease

The overall mission of our administrative core is to integrate the research program components
and to support our training mission. The core will provide seamless oversight, coordination and
leadership to the scientific, administrative and information technology (IT) infrastructure. Core
personnel will oversee and implement the administrative and fiscal aspects of this project
program grant application. Further, the core will supply data management and computing
services, including web-based services, hardware solutions and advice on big data analyses, for
the whole program. Through the core, we will also provide training in scientific writing through
manuscript editing. In addition to serving as the overall principal investigator, Dr. Nahrendorf will
direct project 2 and the administrative core. He is responsible for administrative oversight of all
research. Dr. Nahrendorf will work closely with his associates to ensure regularly scheduled
meetings among investigators, proper administration of all project and core budgets and timely
completion of scientific progress and milestones. The core will assist Dr. Nahrendorf with a
number of administrative services, including preparation of progress reports if this application is
selected for funding.

Public health relevance
The overall mission of our administrative core is to integrate the research program components and to support our training mission. The core will provide seamless oversight, coordination and leadership to the scientific, administrative and information technology infrastructure.